Noninvasive therapeutic hypothermia for tinnitus

Project Summary
Tinnitus is a common medical symptom that is debilitating and life-changing for a significant population with the
primary risk factors that involve peripheral hearing loss, ototoxic medication, otological diseases, and head injury.
It is estimated to affect between 10 to 20% of adults worldwide. While many patients cope with tinnitus, nearly
1 in 10 (or more) experience severe symptoms leading to significant decrease in quality of life and socioeconomic
burden to the society. Despite significant health burden presented by tinnitus there exists no cure and there are no
short term/acute therapies for reducing tinnitus loudness. The proposed project aims to test whether the non-
invasive, non-pharmaceutical delivery of mild therapeutic hypothermia (MTH) targeting multiple cellular and
molecular pathways in the inner ear provides symptomatic relief of tinnitus and reduces tinnitus severity.
RestorEar’s long-term goals are to develop localized therapeutic hypothermia as a non-invasive intervention for
symptomatic relief of tinnitus and to manage tinnitus severity, providing acute relief to patients with chronic
tinnitus. We have already shown that using our novel device ReBoundTM, MTH can be applied quickly following
onset of trauma to modulate protective mechanisms in the cochlea. Here, this approach will be extended to a
group of patients suffering from tinnitus. We will measure the effects of this experimental intervention using
standard and validated psychometric and audiometric functional assessments. With strong results collected during
this Phase I project, we aim to show that MTH delivered to the inner ear will mitigate tinnitus severity and lead
to a new approach for acute and chronic tinnitus management. This approach carries high potential for rapid
translation to the clinic. We will test and optimize this treatment in a randomized clinical study. These results are
expected to lead to a larger multi-site study in Phase 2. Combined with the commercialization of FDA cleared,
patient-ready devices (“ReBoundRx”), the clinical studies proposed will establish a novel therapy for
symptomatic relief and management of tinnitus.

Public health relevance
Public health relevance: RestorEar Devices aims to develop mild therapeutic hypothermia (MTH) as a treatment for acute and chronic hearing conditions, including tinnitus and noise-induced hearing loss (NIHL). RestorEar has developed consumer, clinical, and surgical devices utilizing the novel application of the time-tested therapy and is working to translate the technology to the clinic. Currently, our devices and the therapeutic efficacy of MTH are being investigated in two separate human clinical trials. For this proposal, in collaboration with industry partners and the University of Miami, the efficacy of hypothermia for symptomatic relief of tinnitus will be investigated in a clinical population. The results from this pilot study will lead to a major therapeutic advancement for patients suffering from chronic and acute tinnitus. The proposed research will be highly impactful given the significant health burden and an unmet clinical need of effective therapeutic approaches for reducing tinnitus severity in patients. Commercialization barriers are relatively modest given the simplicity of the hypothermia device and the relative safety of the approach. Results collected from the Phase 1 study will support an expanded trial (Phase 2 SBIR application expected). We aim to achieve De Novo clearance for the device and its application that will benefit a large population suffering from tinnitus.